Spatiotemporal interrogation of interactions of pneumolysin, pulmonary epithelium, and PMNs that result in age-associated susceptibility to Streptococcus pneumoniae disease

PROJECT SUMMARY/ABSTRACT
Streptococcus pneumoniae (Sp) is the most common cause of community-acquired pneumonia and the elderly
are at increased risk of disseminated infection. A hallmark of Sp infection is robust polymorphonuclear leucocyte
(PMN/neutrophil) influx, driven by upregulation of the 12/15-lipoxygenase (12/15-LOX) pathway, which produces
the chemoattractant hepoxilin A3 (HXA3). HXA3 also triggers tissue-destructive neutrophil elastase (NE) release
by PMNs, and NE inhibition diminishes Sp bacteremia. Thus, while PMNs are essential for Sp infection control,
excessive PMN influx also drives tissue damage. Age-associated increases in inflammation and decreases in
apical junctional complex (AJC) components critical for barrier integrity contribute to susceptibility of the elderly
to Sp disease; reduction of Sp bacteremia levels in aged mice to that of young mice requires both PMN NE
inhibition and epithelial barrier fortification. Notably, the Sp virulence factor pneumolysin (PLY) drives both direct
AJC disruption and 12/15-LOX expression. PLY- and age-mediated AJC weakening may also diminish PMN
function, as PMN mechanosensing during transendothelial migration enhances their killing activity. The level of
PLY production is a key determinant to inflammation and barrier disruption, but is heterogeneous. Thus, with
PLY and PMNs as marked examples, a detailed understanding of Sp lung infection pathogenesis requires
investigation of the relationship between anatomic location, tissue microenvironment, and heterogeneity of
microbial and host cell phenotypes. In contrast, studies of Sp pulmonary infection to date have examined only
global readouts of the behavior of populations of bacteria, epithelial cells, and PMNs. We posit that during Sp
lung infection, ply expression results in localized AJC disruption and epithelial 12/15-LOX expression, driving
focal PMN migration and epithelial damage. This is exacerbated by intrinsic diminished AJC integrity and
enhanced PMN NE secretion in aged hosts. To test this model, Aim 1 utilizes confocal microscopy analysis of
Sp infection (wild type, ∆ply) of young and aged mice to quantify Sp ply expression at the single bacterium level
in situ, to elucidate the spatiotemporal relationships of PLY-producing Sp, 12/15-LOX expression, and PMN
recruitment. We will also identify the cells that express 12/15-LOX in response to Sp and determine their
proximity to transmigrating PMNs, and the effect of aging on these parameters. In Aim 2, analysis of intravascular
and transmigrated airway PMNs by flow cytometry or thick tissue 3D confocal imaging of optically cleared tissue
will be used to determine how local PLY- and age-mediated weakening of epithelial AJCs may alter PMN
phenotype and bactericidal activity. Together, these studies will establish both a new framework understanding
of how Sp-host epithelial interaction heterogeneity affects local PMN response and the effect of aging on these
interactions, as well as tractable methods to explore mechanistic details of this framework in situ.

Public health relevance
PROJECT NARRATIVE Streptococcus pneumoniae (Sp) is the most common cause of pneumonia acquired outside the hospital setting and the elderly disproportionately suffer life-threatening systemic disease upon Sp spread from the lung. This proposal seeks to elucidate how local interactions of Sp with the lung epithelium drive excessive, tissue- damaging, polymorphonuclear leucocyte (PMN) infiltration focally and alter PMN function in young versus aged hosts. This detailed understanding of age-related changes that lead to increased susceptibility to Sp will provide knowledge critical for improving treatments for the elderly.